Promoting Health, Safety, and Recovery Training for COVID-19 Essential Workers and their Communities

WRUC COVID Resource and Recovery Centers
Project Summary/Abstract
The overarching goal of this proposed initiative is establish a network of COVID Resource and Recovery
Centers in the Western Region with the capacity to meet the critical needs of essential workers and
communities disproportionately impacted by COVID-19. WRUC will achieve this goal through
engagement with worker and community organizations that maintain trusted relationships with key
target groups, many of whom have already pivoted their activities to respond to the COVID-19 crisis. The
model we propose will extended much needed resources, training, and technical assistance to these
organizations to maintain and expand these local efforts, while also promoting collaboration and
exchange between participating network members.

Public health relevance
WRUC COVID Resource and Recovery Centers Project Narrative This initiative will build the capacity of local worker and community organizations to engage in response and recovery to both infectious disease outbreaks and other disasters in the Western Region. The proposed partnerships and activities are grounded in principles of health equity and diversity, by targeting resources to organizations that have existing relationships with essential workers and communities disproportionately impacted by COVID and supporting those organizations in adapting their approaches to best meet the immediate and future needs of their constituents.